Bone Histology and Imaging

PROJECT SUMMARY/ABSTRACT
The proposed Center for Musculoskeletal Disease Research (CMDR) at the University of Arkansas for
Medical Sciences (UAMS) includes the establishment of the Bone Histology and Imaging Core (Core C). The
scientific theme of the proposed CMDR is the identification of the molecular causes of diseases and conditions
that negatively impact the musculoskeletal system or interact with this system as part of their disease process.
The Bone Histology and Imaging Core is consistent with this theme in that it will deliver to the Project Leaders
state-of-the-art quantitative tissue and cellular data for the characterization of the structural, tissue, and cellular
changes that underlie the pathological mechanisms of the musculoskeletal diseases being studied. The Bone
Histology and Imaging Core will therefore be a critical component for the success of the Project Leaders. The
Core will consolidate existing equipment on the UAMS campus into a large, modern research space within the
Department of Orthopaedic Surgery and will hire experienced personnel on the campus, which will be supervised
by a Core Leader. The specific aims are: 1) To establish the Bone Histology and Imaging Core; 2) To deliver
state-of-the-art musculoskeletal imaging, biomechanical testing, and histology services and introduce new
analytical technologies to CMDR Project Leaders and faculty; 3) To provide bone histomorphometry training and
support educational activities. The success of the Bone Histology and Imaging Core, in conjunction with the other
CMDR cores, will support the development of a critical mass of investigators that will ensure the long-term
sustainability and productivity of the Center.